Multimodal Approaches to Neurobiology of Traumatic Dissociation

Dissociative symptoms in traumatized individuals are common, debilitating, and costly; however, little is
known about how its biological mechanisms interact with PTSD treatment. Traumatic dissociation broadly
encompasses a range of distinct, yet clinically interrelated symptoms: depersonalization, derealization,
amnesia, numbing, flashbacks, passive influence phenomena, and identity disturbances. Either alone or in
various combinations, these symptoms serve as diagnostic criteria and commonly associated features across
multiple psychiatric disorders. Traumatic dissociation is also associated with significant personal and societal
burden. Traumatized individuals with dissociative symptoms typically have co-occurring psychiatric conditions,
high rates of self-destructive behaviors and suicidality, and are disproportionate treatment utilizers. In addition,
they are at increased risk for attrition, non-response and relapse following treatment interventions. Despite the
significant and disabling nature of traumatic dissociative symptoms, little is known about the neurobiology of
these processes and targeted interventions do not exist.
PTSD treatment studies have neither looked at neural intermediate phenotypes of dissociation, nor how
these are associated with psychophysiological and digital phenotypes. Compared to clinical symptom
measures, these biological and in-the-moment digital markers of dissociation may more robustly map onto the
underlying core aspects of the disorder differentiating dissociation subtypes following childhood and adult
trauma. We propose to build upon our prior Exploratory R21 to now capture longitudinal multimodal phenotype
data related to dissociation, pre-, post- and during PTSD treatment modalities that include empirically-derived,
exposure-based components.
The goals of this study will be 1) to understand the differential biomarkers that map onto dissociative
symptoms, and 2) to understand how these biomarkers may best predict trajectory of response to empirically
based standard-of-care treatments. For each of these Aims, we will collect Neuroimaging, Physiology, and
Digital Phenotyping data, applying computational modeling with multimodal data to provide machine-learning
based, unbiased predictive models of dissociative intermediate phenotypes at baseline and longitudinally. This
naturalistic study will allow us to map the biology of dissociation, and importantly, the change in dissociative
symptoms and underlying biomarkers over time, using naturalistic evidenced-based treatment for PTSD in 130
treatment-seeking patients with PTSD, and a range of dissociative symptoms.
Successful completion of these Aims will provide a novel and powerful understanding of the biological
markers of dissociation subtypes following trauma exposure, and will identify biological mechanisms for
understanding and treating PTSD with dissociation.

Public health relevance
Pathological trauma-related dissociation is a significant personal and societal burden. This proposal will examine behavioral and biological correlates of dissociation across imaging, physiology, and digital assessments. Results from this proposal will inform how to identify those at risk for these debilitating symptoms, potential brain regions to target for treatment, and may support a new standard of clinical care for PTSD with dissociation.